Core D: Data Management, Biostatistics, and Bioinformatics

Abstract – Data Management, Biostatistics, and Bioinformatics Core D
The Data Management, Biostatistics, and Bioinformatics Core will provide a local and cloud-based data
management system for the entire Program Project that will enable Project-specific analyses, as well as
integrated analyses utilizing data spanning the entire Project. The Core will serve as the centralized data hub
for the establishment of the prospective RESPOND cohort of African American (AA) men with prostate cancer
(PCa). This includes: (1) questionnaire data, including multi-level factors related to social stressors, linkages to
neighborhood socioeconomic indicators that will be collected through the recruitment Core B and primarily
used in Project 1; (2) germline genome-wide genotype data and exome-sequencing data generated as part of
Project 2; (3) somatic and expression data generated as part of Project 3; (4) immune cell profiles assessing
the tumor microenvironment in Project 4; (5) and pathology related assessments of banked tumor specimens
from Core C. The Core will also provide statistical and bioinformatics support and expertise. As a cohesive
unit, the Core will leverage familiarity with data resources and commonalities of analysis across Projects.
Finally, the Core will serve as the foundation for performing integrated analysis. This includes sophisticated
integrated statistical analyses and access of joint results across Projects. The Core’s activities will be primarily
performed within the University of Southern California’s Biostatistics Division and Translational Genomics
group – benefiting from shared computational resources, active collaborations, and recent methodological
developments in statistical approaches, integrated analysis and informatics. The Core is essential to the overall
success of the Program Project as it serves as an incubator to process and store data, advise and complete
Project-specific analyses, and perform and accelerate cross-Project integration and discoveries.

Public health relevance
Project Narrative – Data Management, Biostatistics, and Bioinformatics Core D The Data Management, Biostatistics, and Bioinformatics Core will construct and oversee a local and cloud-based data management system. For the entire Program Project, the Core will also provide statistical and bioinformatics support and expertise to enable Project-specific analyses, as well as integrated analyses utilizing data spanning the entire Project. The Core is essential to the overall success of the Program Project as it serves as an incubator to process and store data, advise and complete Project-specific analyses, and perform and accelerate cross-Project integration and discoveries.